Computational methods for taxa-free microbial biomarker discovery and clinical risk stratification

ABSTRACT
The gut microbiome has shown immense clinical potential for human disease as non-invasive biomarkers and
new therapeutic interventions such as fecal microbiota transplants. A lack of replicable taxonomic associations
across cohorts is currently limiting the clinical potential of the gut microbiome. Most microbiome studies focus
on taxa-level associations because methods to taxonomically profile microbiomes are more mature and less
computationally complex than those for functional profiling. However, the taxonomic composition of the gut
microbiome is not conserved across individuals in different populations, resulting in the need for approaches that
can explain the persistent relationships between different gut microbes and human health phenotypes. Given
that the functional composition of the gut microbiome is more consistent across individuals and microbial proteins
with the same function can originate in different species, my central hypothesis is that protein biomarkers underlie
taxonomic gut microbial associations with human disease and health outcomes. There are no existing methods
to quantify and efficiently map metagenomic short reads to microbial proteins, which is a necessary first step in
identifying protein and peptide-level biomarkers. My objectives are to develop taxa-free frameworks for gut
microbial biomarker discovery with a goal of understanding the role of gut microbial proteins in human disease.
In Aim 1 I will develop and comprehensively benchmark a new tool to efficiently map whole-genome
metagenomic shotgun sequencing reads to groups of homologous microbial proteins originating in different taxa.
In Aim 2 I will develop non-invasive clinical risk stratification methods based on gut microbial proteins and
introduce a pipeline for prioritizing specific microbial peptides for experimental validation. I will demonstrate the
clinical utility of the risk stratification methods I develop by predicting risk from immune-checkpoint inhibitor
therapy from metagenomic sequencing of fecal samples in published cohorts and validating the methods on a
newly sequenced cohort. Successful completion of these aims will enable non-invasive clinical risk stratification
and microbial biomarker discovery for a wide range of human health outcomes. Application of the developed
methods will demonstrate their clinical utility and help clarify the roles of gut microbes in responses to anti-cancer
immunotherapy.

Public health relevance
Project Narrative Despite the clinical potential of the gut microbiome in human disease, taxa-level associations with disease are inconsistent due to differences in taxonomic composition across populations. The functional composition of the gut microbiome is more conserved than taxa; however, existing methods for metagenomic sequence analysis remain taxa based. This proposal aims to reframe metagenomic biomarker discovery by developing new tools to quantify metagenomic reads in a taxa-free manner and introducing new methods for clinical risk stratification based on microbial proteins.